The Impact of Oxidative Stress on Erythocyte Biology

The goal of this multi-site, multi-PI proposal is to gain a mechanistic understanding of the genetic and
environmental factors governing the ability of red blood cells (RBCs) to handle oxidative stress. RBC
transfusion is the single most common therapeutic intervention for hospitalized patients; however, there is
substantial donor-to-donor variability in how RBCs store, circulate, and function post-transfusion. There is
similar variability in recipient responses to transfusion, due to the wide range of diseases requiring this life-
saving therapy. Our preliminary data using mouse models, linked to and followed by human studies,
demonstrate that lipid metabolism, in general, and eicosanoid generation, in particular, predict RBC quality. We
also identified a novel enzymatic pathway (i.e., Steap3) responsible for determining RBC storage quality of
various mouse strains. Finally, we identified a novel role for diet (both iron and fatty acid consumption) in
modifying lipid oxidation in RBC membranes and affecting RBC quality. Together, these findings led to our
central hypothesis that oxidant stress, and factors influencing it, is a critical determinant of RBC storage
quality.
This proposal represents a multi-institutional collaboration of scientists with diverse expertise in transfusion
biology, mouse models, human studies, “omics” approaches, and RBC and lipid biochemistry, aimed to
improve our understanding of genetic and environmental determinants of RBC quality. Thus, in Aim #1, we will
elucidate donor and recipient genetic and environmental factors by which oxidant stress affects RBC
transfusion in mouse models. In Aim #2, we will identify which results in mice are translatable to the human
setting and will provide mechanistic details in humans. The effects of elevated oxidant stress in sickle cell
disease recipients on the biology of the transfused RBCs will also be directly examined. This proposal is
designed to provide dynamic cross-germination between Aims, allowing for iterative and ongoing mechanistic
studies, which simultaneously exploit the strengths and mitigate the weaknesses of animal and human studies,
respectively. This research will lead to innovative and eminently translatable approaches for improving
transfusion therapy and will enhance basic mechanistic understanding of RBC oxidant stress handling.

Public health relevance
This research will examine the mechanisms for how genetic and environmental factors affect the ability of red blood cells to handle oxidative stress and affect the quality of transfused blood. We will also directly examine the effects of elevated oxidant stress in sickle cell disease recipients on the biology of the transfused red blood cells.